Delayed sleep phase and risk for adolescent substance use

PROJECT SUMMARY
Substance use disorders (SUDs) often begin during adolescence. Mounting evidence indicates that delayed
sleep phase (DSP) may confer risk for adolescent substance use (SU) and SUDs. However, the exact nature
of this link and the mechanisms underlying it remain unclear. Circadian misalignment, a mismatch between late
sleep hours and early school start times, is a compelling potential contributor to elevated SU in adolescent
DSP with plausible neurobehavioral mechanisms. We hypothesize that DSP-associated circadian
misalignment decreases impulse control and increases reward sensitivity, thereby increasing SUD risk. The
proposed study will, for the first time, (1) comprehensively characterize the SUD risk profile associated with
adolescent DSP, and (2) probe whether SUD risk is diminished by altering sleep/circadian timing. The study
will assess both established markers of SUD risk and putative neurobehavioral mechanisms (impulsivity and
reward sensitivity). Specifically, we propose a comprehensive, multi-method approach to examining DSP’s role
in SUD risk, combining laboratory, experimental, and longitudinal studies. We will recruit a sample of 150
twelfth graders (17-19 y/o), divided between 100 DSP and 50 normal phase teens. We will focus on cannabis
and alcohol use given their prevalent use in adolescents and evident links to DSP. The lab study compares a
group of DSP adolescents to a group of normal phase adolescents on behavioral and neuroimaging (fMRI)
tasks tapping impulsivity and reward sensitivity, as well as a circadian phase assessment. In the experimental
study, we will probe whether stabilizing circadian phase in the DSP group by using sleep scheduling and
chronotherapeutic approaches (e.g., bright light) improves sleep and neurobehavioral function relevant to SUD
risk. Finally, we include repeated monthly follow-up assessments of sleep and SU to explore longitudinal
associations during the high-risk transition to young adulthood. Aim 1 (Laboratory Study) is to compare a
DSP group to a normal phase group on sleep/circadian factors, neurobehavioral markers, and SU. Aim 2
(Experimental Study) is to probe the impact of a sleep phase-stabilizing manipulation on sleep and circadian
rhythms, as well as neurobehavioral markers of SUD risk. An Exploratory Longitudinal Aim is to!examine the
prospective relationships between DSP characteristics and changes in SU via repeated monthly assessments
during the high-risk transition to young adulthood. The proposed study is significant: it focuses a biologically-
plausible and modifiable sleep phenotype of particular promise, during a developmental period when the
mismatch between DSP and school-imposed early start times is at its worst and overall SUD risk is spiking.
The proposed study is innovative: (1) it examines several promising neurobehavioral pathways to adolescent
SUD, (2) it combines comprehensive and objective measures of relevant constructs, and (3) it includes an
experimental manipulation to probe the mechanisms linking DSP to SUD. Finally, the proposed study will have
substantial impact: it may open up novel sleep/circadian-based avenues for prevention and treatment of SUD.
!

Public health relevance
PROJECT NARRATIVE Mounting evidence indicates that delayed sleep timing may confer risk for adolescent substance use disorders. A mismatch between late sleep hours and early school start times may lead to disturbed sleep and circadian rhythms, as well as increased impulsivity and sensitivity to rewards, and increased substance use in turn. The aims of this research are (1) to examine associations between sleep timing, impulsivity, reward sensitivity, and substance use, and (2) to determine whether stabilizing sleep/circadian timing in adolescents with delayed sleep timing reduces impulsivity and reward sensitivity.